Task A68: Screening Vaccine (and Other Biologics) Platform Technologies using Coronavirus Mouse Immunogenicity as a Model System

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.